Evaluating New Nicotine Standards for Cigarettes - Administrative Core

PROJECT SUMMARY (CORE A)
Use of combusted tobacco continues to devastate public health. The Food and Drug Administration now has
the authority to reduce the nicotine content of combusted tobacco products, potentially rendering cigarettes and
other harmful products less addictive. This renewal application proposes three innovative projects that extend
our work towards understanding the impact of reducing the nicotine content of combusted tobacco in the context
of alternative nicotine and tobacco products. The Administrative Core focuses on addressing the challenges of
conducting the proposed science and enabling the investigative team to take full advantage of the opportunity
to make significant contributions to the field of tobacco regulatory science. Specifically, this includes the following
aims: 1) To provide an infrastructure that facilitates integration across the projects and cores and the
implementation of methods, measures and procedures that yield high quality research. 2) To facilitate
communication and dissemination of information to scientists, policy makers, other stakeholders, and the
community at large. 3) To provide and monitor a training plan for NIH-supported pre-doctoral and post-doctoral
researchers interested in tobacco regulatory research. 4) To generate new science through a pilot projects
program that addresses innovative research questions related to the aims of CENIC, contributes to investigator
training, and fosters collaborations among investigators. The Administrative Core will be housed at the University
of Pittsburgh under the leadership of Drs. Eric Donny and Dorothy Hatsukami (Co-Directors). Each of the four
functions will be overseen by a core member of our team. An External Advisory Board will provide annual input
on the overall direction of the Center, areas that need to be addressed, and progress being made. A single Data
Safety and Monitoring Board will oversee all three projects.

Public health relevance
NARRATIVE (CORE A) The Administrative Core focuses on addressing the challenges of conducting the science related to nicotine product standards for combusted tobacco products and enabling the investigative team to make significant contributions to the field of tobacco regulatory science. Specifically, this includes providing an infrastructure that facilitates integration of all components of the center; implementation of methods, measures and procedures that yield high quality research; communication and dissemination of information; training pre-doctoral and post- doctoral researchers; and generating new science through a pilot projects program.